ID-Cap System: Next generation ingestible sensors for medication adherence measurement

ABSTRACT
Nonadherence to medication therapy results in significant morbidity and mortality across the world. In the
United States, medication nonadherence results in $528 billion of annual costs to healthcare to manage
consequences associated with nonadherence including progression of chronic disease. For medication
regimens like HIV pre-exposure prophylaxis (PrEP) and antiretroviral therapy (ART), morbidity associated with
nonadherence includes acquisition and transmission of HIV, opportunistic infections, and exacerbation of
chronic HIV related comorbidities. In order to understand adherence and mitigate nonadherence, new direct
adherence tools that confirm ingestion events are needed. Current indirect measures detect surrogate
indicators of adherence like self-report, pill counting, or electronic adherence devices that detect the opening of
pill bottles. These methods suffer from recall bias and often provide an incomplete measure of adherence. In
contrast, direct measures, such as directly observed or video observed therapy that utilizes a clinician or
healthcare worker to visually confirm medication ingestion, can verify medication ingestion events. Yet, these
direct methods are expensive, require personnel, and are therefore difficult to scale. Direct confirmation of drug
concentration in serum or hair may be used as evidence of medication adherence, but these methods require
specialized analysis techniques and provide overall adherence which may overlook periods of suboptimal
adherence. In response to the limitations of both indirect and direct measures of adherence, digital pills—an
ingestible radiofrequency emitter and gelatin capsule which over encapsulates the desired medication—
represent a tool that can directly confirm medication ingestions and innovatively provide feedback to both the
user and care team. In 2019, etectRx received FDA 510K clearance for the ID-Cap, a digital pill system that
directly measures medication adherence in real-time. Through K23DA044874 and independent investigator-
initiated research grants from Gilead Sciences, we have demonstrated the feasibility of using the ID-Cap
System among individuals to measure adherence to PrEP and opioids. During these investigations, we
discovered widespread interest among patients in optimizing the system by developing a wrist-borne wearable
Reader to collection adherence information from the digital pill. This Phase I SBIR therefore develops the next-
generation ID-Cap System with a wrist-borne wearable reader. In Aim 1, we will miniaturize the current version
of the Reader and conduct laboratory testing to ensure all components are functional and acquire signal from
ingested digital pills. Next, in Aim 2, we will conduct an open-label pilot demonstration trial to understand the
real-world usability of the next generation ID-Cap System among N=30 individuals on PrEP (N=15) and ART
(N=15). Our benchmarks for success, the development of a miniaturized wrist-worn reader and demonstration
of usability in a clinical trial, will optimally position us to advance commercialization efforts at etectRx in the
context of a Phase II SBIR.

Public health relevance
PROJECT NARRATIVE Nonadherence to medication regimens results in significant morbidity and mortality, especially among individuals on HIV pre-exposure prophylaxis (PrEP) and antiretroviral therapy (ART). Digital pill systems are a method to directly measure and confirm adherence and have been demonstrated as feasible in the real-world, but user feedback has indicated that wearable devices linked to the digital pill system need to be miniaturized. This grant develops a next-generation digital pill system (ID-Cap) with a wrist- borne Reader to measure adherence to PrEP and ART.